Cell and Tissue Imaging (CTI)

The Cell and Tissue Imaging Shared Resource (CTI-SR), is a centralized, shared instrumentation resource
with advanced microscopy and imaging technologies that are vital to studying cell and tissue morphology and
ultrastructure. As such, the facility provides a cost-effective solution for Rogel researchers to utilize state-ofthe-art imaging instrumentation with the technical support necessary to succeed in both routine and advanced
imaging modalities from inception to publication. In addition to offering instrument time, CTI-SR offers routine
and advanced services in electron microscopy sample processing, sectioning, staining, and analysis. The
availability of highly trained personnel with years of expertise is a distinct advantage to Rogel members, as is
the Rogel member subsidy. The facility also emphasizes training to ensure that all users operate the advanced
equipment properly, independent of prior experience.